Phase 1 Safety and Pharmacokinetics of ALK001 in people over 60

DESCRIPTION (provided by applicant): The overall goal of this collaborative research between Alkeus Pharmaceuticals and Columbia University Medical Center is to evaluate a new oral investigational treatment for dry age-related macular degeneration (dry-AMD), the leading cause of blindness in the U.S., and Stargardt's disease, also known as juvenile macular degeneration. The investigational compound is a vitamin A enriched with deuterium, D3-vitamin A. D3-vitamin A slows formation of toxic vitamin A dimers and lipofuscin in the eye, resulting in preserved visual function in the animal models of dry-AMD/ Stargardt's disease. The main hypothesis of this research is that retarding vitamin A dimerization will also slow lipofuscin accumulation and the course of dry-AMD and Stargardt's disease. The primary objective of this grant is to complete a safety evaluation of D3-Vitamin A so that a larger efficacy trial for dry-AMD can be conducted. This safety trial has already been approved by the FDA (open IND). We will achieve this objective by completing the following specific aim. Aim: Complete a one-month (1 week dosing) open label clinical trial to assess the safety of D3- vitamin A and determine whether safe but significant levels of D3-vitamin A can be incorporated into the blood in patents over 60 years of age. Outcome: 1) D3-vitamin A at 1.5 and 3 mg/day is safe, warranting further investigation. 2) Ratio of D3-vitamin A over total non deuterated vitamin A in the blood increases over time upon dosing with vitamin A. Methods: Follow standard blood liver enzymes, blood lipids, urine analysis and plasma D3-vitamin A. Total Duration: 6 months (from first patient screening to report publication) PUBLIC HEALTH RELEVANCE: The proposed research is relevant to overall public health because it seeks ways to better understand, prevent and treat macular degeneration.

Public health relevance
The proposed research is relevant to overall public health because it seeks ways to better understand, prevent and treat macular degeneration.